The Role of Macrophages in Deployment-related Lung Disease in OEF/OIF/OND Veterans

Roughly 3 million U.S. military personnel were deployed to support operations in Southwest Asia and
Afghanistan since 2001. The vast majority experienced deployment-related respiratory exposures (DRREs)
from a combination of burn pit combustion products, particulate matter, and chemical toxins, and many have
developed respiratory symptoms that are now service-connected. Deployment-related lung disease (DRLD)
has symptoms that overlap with bronchiolitis and asthma, but the pathobiology remains unclear and
controversial. There is a significant need to develop diagnostic criteria and therapy for long-term military
readiness.
Pulmonary macrophages (pMacs) are the sentinels of the lung and are the first immune cells to
encounter inhaled toxins. In mouse models, we have shown that aerosolized deployment-related toxins result
in three key alterations to pMacs: (1) sustained intracellular accumulation of toxins, (2) durable epigenetic
alterations to inflammatory pathways, and (3) phagocytic and tissue repair dysfunction. Notably, we also found
accumulation of activated pMacs in lung tissue from deployed OEF/OIF/OND Veterans. We hypothesize that
DRREs induce epigenetic alterations to homeostatic pathways in pMacs resulting in long-term dysfunction and
chronic lung disease. Our proposed studies aim to understand which DRREs contribute most to pMac
dysfunction, how pMacs contribute to DRLD, move closer to diagnostic criteria, and test a targeted therapy.
To achieve these goals, we will first define the specific functional and genomic changes that occur to
macrophages based on the DRRE (e.g., jet fuel vs. sand vs. pesticides). We will conduct paired RNA-seq with
ATAC-seq and DNA methylation analysis to identify sustained epigenetic adaptations which regulate gene
expression. Next, we will use our established mouse model of DRREs with adoptive transfer and selective
depletion of pMacs to define their role in the development of pulmonary pathology and dysfunction. Finally, we
will evaluate the ability to repurpose a novel immune-targeted drug to prevent and/or revert exposure-induced
immunopathology in our DRRE mouse models.
Collectively, these studies directly address several programmatic goals related to DRREs: (1)
understand pathobiology, (2) evaluate immune parameters, and (3) define epigenetic signatures. Our proposal
is innovative because it focuses on epigenetic changes to immune cells that can be detected in sputum and we
will test a targeted drug that is already available. This could have high impact for Veterans and active U.S.
military as the pathobiology and diagnostic criteria for DRLD remain a challenge for clinicians and no targeted
therapeutic options are available.

Public health relevance
Roughly 3 million military personnel who served in Afghanistan and Southwest Asia post-9/11 experienced respiratory exposures from burn pit combustion products, particulate matter, and chemical toxins. Subsequently, many developed deployment-related lung disease (DRLD), severely compromising their ability to lead a normal life. Although this is now service connected, how respiratory exposures result in DRLD is poorly understood, and therefore diagnosis and therapy are challenges for clinicians. Using mouse models, we found that deployment- related toxins cause chronic disruption of the immune system in the lung, driven by alterations in how genes are expressed (epigenetics). Our proposal seeks to clarify which exposures are most detrimental to proper immune function (e.g., jet fuel vs. sand vs. pesticides), determine how dysfunctional immunity leads to DRLD, and test an immune-targeted drug in clinical trials for patients with chronic inflammatory lung disease. If successful, these studies may lead to improved diagnostic criteria for Veterans, as well as a new way to treat and/or prevent DRLD.